NUCATS CTSA UM1 at Northwestern University

PROJECT SUMMARY/ABSTRACT
Over prior funding cycles, the Northwestern University Clinical and Translational Sciences (NUCATS) Institute
has developed and delivered a robust institutional infrastructure to support clinical and translational research.
Our mature CTSA hub has made exceptional contributions to the consortium, attaining national prominence for
igniting cross-disciplinary team science and boundary-crossing partnerships. These strengths now enable
NUCATS to pivot and focus on clinical and translational science (CTS). This proposal addresses three of the
most urgent and fundamental priorities to accelerate and catalyze translation: (a) cultivating a culture of
inclusive excellence to better capitalize on our full range of talent and enable effective translation for diverse
populations; (b) accelerating discovery and development of innovations in interventions and processes to
improve efficiency of translation; and (c) infusing implementation science (IS) methods into work across the
translational continuum to increase the demand for and supply of effective health services to improve public
health. NUCATS will develop, evaluate, and disseminate more effective health interventions to more patients
more quickly through teamwork with our exceptional coalition of community, health system, and CTSA partners
via three Specific Aims: INCLUDE, INNOVATE, and IMPLEMENT. For our INCLUDE Aim, we will work to
cultivate a culture of inclusive excellence as we expand our workforce, partnerships, and research participants,
including those historically underrepresented in biomedical science, to optimize the beneficial impacts of
translation on the health of all. For our INNOVATE Aim, we will catalyze innovation across all stages of the
translational continuum to promote entrepreneurship as well as the rigor and reproducibility of translational
research. For our IMPLEMENT Aim, we will infuse implementation science methods into clinical research
across the translational continuum to accelerate public health impact. Each Specific Aim will be attained via a
set of Strategies, which in turn consist of a set of Initiatives. Pursuit of the Specific Aims will be overseen by a
highly interactive Multiple Principal Investigator (MPI) team ideally suited to provide strong oversight of the
Specific Aims, with each MPI having primary oversight of one aim. The MPIs will tightly coordinate a team-
based leadership structure emphasizing integration across hub and application components, supported by
Advisory Committees. This proposal is further enabled by our renowned evaluation infrastructure, our
longstanding leadership in open science principles (including Findable, Accessible, Interoperable, Reusable
(FAIR) data) and our track record of leadership across the CTSA consortium. By the end of the proposed UM1,
NUCATS will become a national champion and consortium resource for transdisciplinary research teams
seeking to continuously improve CTS performance to more efficiently deliver inclusive, innovative, and
implementable solutions that improve health for all.

Public health relevance
PROJECT NARRATIVE The mission of this Northwestern University Clinical and Translational Science (NUCATS) UM1 proposal is to transform clinical and translational science to improve health for all. NUCATS will continue to serve as a hub for clinical and translational research across Northwestern University and its clinical affiliates, Northwestern Medicine, Ann & Robert H. Lurie Children’s Hospital of Chicago, and the Shirley Ryan AbilityLab. NUCATS will build upon its exceptional strengths in cross-disciplinary team science and boundary-crossing partnerships to address three Specific Aims: to advance inclusive excellence in our workforce, community partnerships, and research participants (INCLUDE); to harness innovation to enhance entrepreneurship as well as the rigor and reproducibility of research (INNOVATE); and to infuse implementation science into work across the translational continuum in our health system and with community partners (IMPLEMENT).